Neural Mechanisms of Behavioral Coordination in Hydra

PROJECT SUMMARY
How do animals coordinate their many parts to generate coherent, adaptive behavior? Are there neural
mechanisms that coordinate whole animal neural activity thereby coordinating whole animal behavior?
Numerous low-resolution studies in mammals have revealed a highly conserved hierarchy of spontaneous brain-
wide oscillations spanning a wide range of frequencies in which slower, more global oscillations appear to
coordinate and constrain faster, more local oscillations via various cross-frequency coupling mechanisms.
However, whether and how slow global oscillations might coordinate whole brain activity and, thus, whole animal
behavior, remains obscure due to the difficulty of measuring, manipulating, and modeling whole mammalian
brains with high spatiotemporal resolution. Fortunately, spontaneous brain-wide oscillations have also been
found in zebrafish, bees, fruit flies, and even the cnidarian, Hydra vulgaris, indicating significant evolutionary
conservation of these oscillations, particularly the ultraslow (0.01-0.1 Hz) rhythms. Hydra possesses the simplest
known nervous system and allows simultaneous calcium imaging of its entire nervous system during behavior,
enabling observation of all rhythms in parallel with single cell resolution. In addition, Hydra exhibits robust
behaviors that have been categorized and quantified using machine learning, allowing precise correlation of
global neural activity with fine-grained behavior. Thus, here I propose to use this highly tractable system to test
the hypothesis that the spontaneous ultraslow network of Hydra—rhythmic potential 1 (RP1, 0.1-0.01 Hz)—
serves as an organizer and coordinator of global neural activity to generate unified, coherent behavior. I predict
that disruption of RP1 activity will result in disorganized global neural activity and uncoordinated behavior, as
preliminary data indicate. The studies proposed here will directly test the causal link between spontaneous
ultraslow oscillations and global neural activity and behavior. To elucidate the role of RP1 in Hydra, I will first
employ single neuron resolution whole nervous system calcium imaging and behavioral analysis to determine if
RP1 activity is predictive of both global neural activity and behavior and whether it regulates the other major
networks in the animal via cross-frequency coupling. Next, I will determine if development of distinct RP1
networks is correlated with development of distinct and uncoordinated global neural activity and behavior in
budding Hydra. I will then disrupt the RP1 network physically, optically, and pharmacologically to determine if its
disruption results in uncoordinated global neural activity and behavior. Together, this proposal will shed light on
a major unanswered question within neuroscience: the role of spontaneous neural activity, particularly ultraslow
oscillations, and whether they might serve to coordinate global neural activity and behavior. This project will also
provide me with the training I need to launch a successful independent research career.

Public health relevance
PROJECT NARRATIVE A hierarchy of spontaneous neural oscillations spanning a wide range of frequencies is one of the most highly conserved aspects of all brains, yet we have little understanding of its potential function due to the difficulty of imaging and manipulating whole brains. This proposal aims to address this problem using the cnidarian, Hydra vulgaris, which possesses one of the simplest known nervous systems in which all neural oscillations in the animal can be observed in parallel with single neuron resolution. These studies will directly test whether spontaneous ultraslow frequency oscillations might serve as organizers of global neural activity and behavior and may shed light on the role of these oscillations in more complex organisms, including humans, in which such brain-wide oscillations have been found to play important, yet poorly understood, roles in a wide array of neuropsychiatric disorders.